Hematopoietic and GI acute radiation Syndromes and Radiation Injuries

There are a total of 5 work plans that cover animal model development for efficacy testing of drugs to treat hematopoietic and GI acute radiation syndromes and radiation combined injuries in mouse models, and development of large animal models of radiation injuries to the total body and skin.